Infralimbic circuit control over a sex-dependent switch in threat responding

Project Summary
Sex differences in the development and prevalence of mental illnesses are widespread, suggesting that the
factors that promote disease risk and resilience may be distinct in men and women. The neurobiological
mechanisms underlying this possibility are poorly understood, however, because the vast majority of pre-
clinical animal research has been conducted in males. In addition, the behavioral outcome measures used to
understand learned fear have focused predominantly on passive, or freezing behavior. We recently identified
an active, escape-like conditioned fear response in rats (“darting”) that occurred almost exclusively in females
and was predictive of improved extinction retention. A better understanding of potentially sexually dimorphic
mechanisms that drive this behavior could open new avenues for treatment of disorders that are more
prevalent in women, like PTSD. We propose here to define the neural circuitry that drives the selection of
conditioned darting vs. freezing, and how that integrates with known extinction circuits to promote extinction
retention. Our preliminary data implicate the infralimbic cortex (IL) in this role, and we will use pharmacological,
chemogenetic, and viral techniques to probe how descending IL projections to the dorsal and ventral
periaqueductal gray (PAG) may mediate a strategic switch between active and passive responding and drive
long-term behavioral flexibility through putative collaterals in the amygdala. We will then use sophisticated
machine vision and machine learning-based tools to define the broader behavioral repertoires within which
darting exists, thereby identifying a multifaceted phenotype that could provide insight into the mechanisms
underlying individual differences in stress resilience and vulnerability.

Public health relevance
Project Narrative Sex differences in the development and prevalence of mental illnesses are widespread, suggesting that the risk factors that promote disease susceptibility may be distinct in men and women. This project explores the neurobiological basis of divergent (active vs. passive) fear responses in males and females, which could help identify novel ways to prevent or treat post-traumatic stress disorder.